International Conference on Medical Image Computing and Computer Assisted Interventions (MICCAI) 2020

Project summary The Medical Image Computing and Computer Assisted Interventions (MICCAI) society is dedicated to the promotion, preservation and facilitation of research and education in the fields of medical image computing and computer assisted interventions, including biomedical imaging and robotics. This aim is achieved through the organization and operation of regular international conferences of the highest quality, and publications that promote and foster the exchange and dissemination of advanced knowledge, expertise and experience by leading institutions and outstanding scientists, physicians, and educators around the world. MICCAI Conferences have their origin in three separate but related conferences beginning in early 1990s--Visualization in Biomedical Computing, Computer Vision and Virtual Reality in Robotics and Medicine, and Medical Robotics and Computer Assisted Surgery--, which merged into a single annual conference in 1998. MICCAI Conferences have defined new scientific disciplines over the years and have become the premier meeting in the field. The conference proceedings have an impact factor comparable to high-impact computational journals. Conference topics include, computer vision & medical image processing, computer-aided diagnosis, interventions & surgery, machine learning in medical imaging, guidance systems & robotics, visualization and virtual reality, bioscience and biology applications, imaging systems and new biomedical imaging applications, spanning disciplines such as radiology, pathology, surgery, oncology, cardiology, physiology, and psychiatry. The MICCAI conference includes three days of oral presentations and poster sessions. The quality and importance of poster presentations are considered to be on a par with those of oral presentations, with both undergoing a rigorous double-blinded peer-review (~30% acceptance). Selected presented papers became landmark publications over the years with up to 2,000 citations. The conference series includes satellite events like community-driven software challenges, workshops and tutorials just before and/or after the main conference. These events focus on the current status and advances in topics relevant to MICCAI and are very well attended. The MICCAI Conferences span the entire globe and are usually rotated among the American, European, and Asian continents. Attendees are typically from over 45 countries, with strong student representation (>40%). The MICCAI 2020 Conference will be held in Lima, Peru in October 4th-8th, 2020. Since 2018, a Mentorship Program to connect students and young investigators with established mentors from academia and industry is also part of the conference. Along with the Mentorship Program and mission of the “Women in MICCAI” Committee, this proposal requests funds to support student and early investigator travel awards to enhance diversity in conference attendance (including women, underrepresented minorities, students with disabilities, and people from disadvantaged backgrounds) and provide minority groups with a unique opportunity to reach an international audience for career development and collaborations.

Public health relevance
Project narrative The Medical Image Computing and Computer Assisted Intervention (MICCAI) 2020 Conference will be held in Lima, Peru, October 4th-8th, 2020. MICCAI is the premier meeting in the medical image computing and computer assisted intervention communities, having introduced landmark papers and providing a springboard for young scientists to establish themselves in the field. This proposal requests funds to provide travel awards for students and early investigators to present their work at MICCAI 2020--with focus on minority groups and underrepresented populations--providing them with an opportunity to attend the meeting, foster professional development and identify collaborations in an established international community.